Metalloenzymes and metal homeostasis

Project Summary
The goal of this administrative supplement request is to facilitate protein isolation for the biochemical,
spectroscopic, and structural studies central to this research program. All aspects of the funded projects require
protein purification by FPLC. The proposed ÄKTA Pure 25 M will replace obsolete equipment and ensure
continued productivity at a high level.

Public health relevance
Project Narrative Methane gas is a major contributor to climate change, which represents a significant threat to human health. Methane-consuming bacteria have the potential to mitigate methane emissions and also produce copper-binding natural products with promising therapeutic applications. This equipment will be used to purify methane-oxidizing and natural product biosynthetic enzymes.